Estimating the Impact of Structural Factorson HIV Transmission: A Multi-agent Spatial Simulation Modeling Study

PROJECT SUMMARY/ABSTRACT
The disparity in HIV incidence rates between African Americans/Blacks and whites continues to
grow. Interventions aimed towards reducing HIV incidence by changing individual-level behaviors
have been implemented among African Americans/Blacks. Unfortunately, there has been little to
no success in closing the gap between the two racial groups. Many studies have determined
neighborhood-level factors (e.g., neighborhood disadvantage, poverty, and incarceration)
significantly influence HIV-related risk behaviors, engagement in testing and treatment, and
adherence to HIV care and mortality among African Americans/Blacks, especially those who
identify as heterosexual. In this study, we will develop a multi-agent spatial simulation model that
will estimate the effect of neighborhood-level factors such as neighborhood disadvantage and
gentrification on HIV incidence among heterosexual African American/Black adults to develop
interventions that can reduce transmission among this population. We will first implement spatial
dynamics into an agent-based model to create the multi-agent spatial simulation model. We will
then estimate the effect of neighborhood disadvantage on HIV incidence among heterosexual
African American/Black adults. Next, we will evaluate the effect of migration and gentrification on
HIV incidence within this population by integrating migration into the model. Using innovative
methods such as multi-agent spatial simulation modeling, we will simulate the complex
interactions between individual-level behaviors, networks, and neighborhoods for estimating the
structural influence of HIV on a population level and test structural-level interventions. We will be
the first to develop a spatially dynamic model for studying HIV among heterosexual African
American/Black adults in an urban setting through the development of the model. This research
will also be used as a framework for estimating structural influences on populations in different
jurisdictions within the United States to reduce HIV-related disparities and the structures that allow
it to prosper.

Public health relevance
PROJECT NARRATIVE Neighborhood-level factors such as neighborhood disadvantage, incarceration, and poverty have been shown to influence individual-level HIV risk behaviors and HIV outcomes among heterosexual African American/Black adults. Using agent-based modeling as a foundation, this study will be among the first to implement spatial dynamics into a mathematical model to estimate the effect that neighborhood-level factors such as neighborhood disadvantage and gentrification have on HIV incidence among heterosexual African American/Black adults in urban settings. Through the development of this model, we will be able to test structural-level interventions (e.g., increasing access to healthcare facilities and implementing tax reform policies for reducing displacement from gentrification) that can be used for reducing HIV incidence among this population, and create a framework that can be adapted for studying various neighborhood-level influences on populations in different jurisdictions.